Core--Transgenic animal model

The Transgenic Animal Model Core will be responsible for making all transgenic mice described in this Program Project application. The investigator will design and generate the gene construct. The Core will do the microinjections to produce the transgenic mice. The Core will provide the investigator with a sample of tail DNA or peripheral blood for analysis, and the investigator will report which mice contain the transgene. The Core will establish the lines of transgenic mice, and will freeze embryos from each line, if desired. Once a line is established, the Core will maintain the line to provide sufficient experimental mice for the investigator.